Administrative Supplements to Participate in the NCI Early-stage Surgeon Scientist Program (ESSP)

PROJECT SUMMARY ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as "NOT-
CA-21-100." Esophageal cancer (EC) is the sixth most common cause of cancer deaths worldwide, with 5-
year survival of 20%. The two primary subtypes of EC, esophageal squamous cell carcinoma (ESCC) and
esophageal adenocarcinoma (EAC), demonstrate markedly different sensitivities to standard-of-care
neoadjuvant regimens, including chemotherapy and chemoradiation prior to esophagectomy, and adjuvant
immunotherapy protocols for residual disease. Given their differential sensitivities to treatment, there is a
critical need to identify the unique vulnerabilities of ESCC and EAC and develop tailored treatment regimens
for each histology, which historically have been treated as a single disease. The transcription factor p63 is a
marker of squamous cell differentiation, and our preliminary data have shown that it is highly expressed in
ESCC cell lines and absent in EAC cell lines. P63 is a known regulator of cellular metabolism, with
established roles in promoting glycolysis and redox homeostasis in both embryonic development and
squamous cell tumors, while the absence of p63 results in glucose intolerance and metabolic syndrome. We
aim to determine the role of p63 in defining metabolic programs that underlie ESCC and EAC histologies in
order to define their unique metabolic vulnerabilities and identify novel therapeutic targets, towards a more
personalized treatment approach for esophageal cancers. Through the proposed Specific Aims and Career
Development Plan, we will quantify the flux through metabolic pathways that define ESCC and EAC and
determine their dependence on p63 isoform expression, correlating these results with markers of squamous
and glandular differentiation. Furthermore, we will validate these results against metabolome profiles of
treatment-naïve ESCC and EAC tissue samples. In Aim 2, we will define direct and indirect metabolic targets
of p63 isoforms in esophageal cancer cell lines and organoids using CUT-and-RUN and transcriptomics
analyses, and integrate these datasets using multi-omics approaches to define the metabolic network
downstream of p63. Studies will be performed in 2D and 3D cultures using established cell lines and patient-
derived organoids, as well as patient-derived biopsy samples, and utilize functional genomics, high throughput
metabolomics, and multi-omics integration in novel 3D culture models that recapitulate the native architecture
and physiology of human esophagus and esophageal cancers. The results of these studies will provide novel
insight into the unique metabolic vulnerabilities of ESCC and EAC that underlie their sensitivity and resistance
phenotypes, and will provide the basis for future studies to establish new metabolic targets for treatment of
this deadly disease.

Public health relevance
This project is relevant to public health because improved molecular understanding of esophageal cancer, focusing separately on esophageal adenocarcinoma and squamous cell carcinoma subtypes, is necessary to develop more effective treatment strategies for this disease, which has only 20% 5-year survival. Our work will identify new targets that are unique to esophageal cancer subtypes based on their underlying metabolism. This project is therefore directly relevant to the NCI’s mission to advance scientific knowledge that will improve patient survival and train the next generation of cancer researchers through this career development award.